The cellular and molecular signatures of postnatal human RTT astrocytes

Summary
Mutations in the X-linked gene, methyl-CpG binding protein 2 (MECP2), underlie a wide range of
neuropsychiatric disorders, most commonly Rett syndrome (RTT), a severe neurodevelopmental disorder.
Despite numerous studies, the question of why the loss of MeCP2 results in RTT remains largely unanswered,
and it represents a major challenge from both basic biological and therapeutic standpoints. Our previous
studies, based on mouse models, advanced the knowledge of the disease and the specific cell types involved
in the RTT neuropathology. We showed that mutant glia, specifically astrocytes, are integral part of RTT and
that healthy astrocytes are able to rescue many aspects of the disease. However, mouse models do not
represent properly human RTT, which is known to be more severe than in mouse models. Importantly, human
astrocytes are significantly different than mouse astrocytes, both in their structure and in the gene expression
landscape. In the past decade, RTT patient-derived iPSCs have been used to generate neurons and glia in
monolayer as a model for human RTT. While this model is useful, it does not reflect faithfully the generation
and maturation of neurons and glia in the developing brain. We propose to generate 3-dimensional (3D)
human cortical spheroids (hCSs) derived from human pluripotent stem cells (hPSCs) as a model for RTT brain
development, in order to produce, isolate, and study mature astrocytes. We will exploit the advantages of the
long-term 3D spheroid model, which allows structural, transcriptional and functional maturation of astrocytes,
resembling the human postnatal maturation stage, which parallels the onset of RTT. We will determine how
RTT-causing mutations in MECP2 affect the intrinsic properties of mature postnatal human astrocytes when
they develop and mature with neighboring neurons, their ability to support neuronal structural plasticity, their
gene expression profile, and their metabolic signatures.
Modeling the development and maturation of human RTT astrocytes and analyzing their cellular and
molecular properties at a stage which parallels the onset of RTT will provide important insights into the non-cell
autonomous mechanism of RTT and serve as a platform for developing therapeutic strategies to reverse the
impaired human RTT neuronal networks.

Public health relevance
Narrative We established an important role for glia in Rett syndrome, and the ability of glia, specifically astrocytes, to rescue RTT-like phenotypes in mouse models. To shed new light on the role of astrocytes in RTT, we will use the human model for RTT brain to recapitulate astrocytes’ development and maturation and analyze their cellular and molecular properties. The proposed studies have the potential to advance our understanding of the contribution of mutant human astrocytes to the RTT neuropathology and to identify potential targets to rescue common aberrations in mature astrocytes and thereby restore the support to the neurons in RTT models and, ultimately, patients.